Regulation of parallel recycling pathways at synaptic sites

PROJECT SUMMARY/ABSTRACT
Phosphoinositide signaling lipids are key regulators of endomembrane trafficking and are critical for synaptic
function and plasticity. Notably, many synapse-specific trafficking pathways are highly similar to cognate
pathways in non-neuronal cells. The specialized trafficking at synapses is largely achieved via modest
alterations to generic trafficking pathways. Due to the high demand of traffic at synapses, very minor mutations
in these pathways specifically impact the nervous system and underlie a wide range of neurological disorders.
PIKfyve and its regulatory proteins Vac14 and Fig4 control the cellular levels of the low abundance
signaling lipids phosphatidylinositol (3,5)-bis phosphate (PI3,5P2) and phosphatidylinositol 5- phosphate
(PI5P). Studies from us and others revealed that minor mutations in this pathway are associated with several
neurological disorders. Insights into roles of PI(3,5)P2 in neurons came from our discovery that PIKfyve plays
essential roles in synaptic function and plasticity, and acts in part via controlling the surface levels of AMPA-
type glutamate receptors (AMPARs). PIKfyve downregulation results in enhanced recycling and surface levels
of AMPAR, although the underlying molecular mechanism(s) are unknown. Paradoxically, our new studies in
non-neuronal cells, reveal that PIKfyve has a direct positive role in the control of the SNX17 recycling pathway.
Notably, both the SNX17 and SNX27 pathways emerge from the same microdomains on endosomes. This
places PIKfyve on endosomes that actively recycle both SNX17-dependent and SNX27-dependent cargoes.
Importantly AMPAR surface levels are controlled in part via SNX27-dependent recycling. Aim 1 of this proposal
seeks to determine whether PIKfyve controls AMPAR surface levels via negative regulation of SNX27-
dependent recycling.
Importantly, our new studies raise the possibility that dysregulation of SNX17 during PIKfyve inhibition,
may also contribute to the observed synaptic defects. Mutations in proteins that function with SNX17 underlie
some neurological diseases, but surprisingly, there are no published studies to establish whether SNX17
recycling is critical for synaptic function. The current project will test the hypothesis that PIKfyve differentially
regulates distinct recycling pathways that emerge from the same endosomes. To address this hypothesis we
will 1) Determine mechanisms whereby PIKfyve regulates AMPAR recycling; 2) Determine roles of the SNX17-
Retriever pathway in neurons and whether similar to non-neuronal cells, PIKfyve is a regulator of this pathway.

Public health relevance
PROJECT NARRATIVE Membrane trafficking of receptors is crucial for synaptic activity. This proposal will further test the hypothesis that a newly discovered trafficking pathway in non-neuronal cells, is also critical in neurons. In addition, this proposal will determine whether this new pathway is coordinated with a previously discovered pathway.